SUBJECT MATTER EXPERT FOR PROCESS CHEMISTRY DEVELOPMENT

The NINDS Subject Matter Expert Consultant for Process Chemistry provides technical guidance to the following programs:

• Process Chemistry consulting to support the NIH Blueprint Neurotherapeutics program [BPN].
• Process Chemistry consulting to support the NIH Blueprint Help End Addiction Longterm [HEAL] program [HEAL].
• Other NIH neuroscience-focused drug discovery and development programs.

The NIH Blueprint for Neuroscience Research, a consortium of 8 NIH Institutes and Centers that support neuroscience research, established the Blueprint Neurotherapeutics Network (BPN) as a pipeline between the typical endpoint of NIH-funded research and the beginning of industry drug development. The BPN provides neuroscience researchers with funding and access to a full range of industry-style drug development services and expertise. The program is intended for projects requiring medicinal chemistry optimization and contract research organization (CRO) support through Phase I clinical testing.